Pancreas Cancer Specific Probe for Image Guided Resection

Pancreas Cancer Specific Probe for Image Guided Resection
This application is being submitted in response to the Notice of Special Interest (NOSI) identified
as NOT-CA-21-100. The incidence of pancreatic ductal adenocarcinoma (PDAC) continues to
rise as does the number of patients eligible for surgical resection due to improvements in
neoadjuvant therapy. Surgical resection with negative resection margins remains the only
opportunity for cure for patients with this disease. However, microscopically positive resection
margins have been reported in up to 75% of patients undergoing resection for curative intent.
Clinically available imaging techniques lack the ability to detect microscopic tumor involvement of
mesenteric vessels or differentiate between fibrosis and live tumor, representing an unmet clinical
need. Development of a PDAC specific near infrared (NIR) contrast agent that can be detected
by multispectral optoacoustic tomography (MSOT) would improve intraoperative detection of
resection margin. This proposal will synthesize a NIR reporter agent that targets plectin-1 peptide,
which is aberrantly located on the surface of PDAC cells. Our synthesized probe will be optimized
for binding with human PDAC. Specificity of the probe will be tested on human PDAC cell lines
and tissue collected from resected PDAC. The most efficiently performing probe will then be
tested for toxicity and performance in vivo in mice. Successful completion of this proposal will
generate a PDAC-specific contrast probe to improve detection of viable PDAC and adjacent
fibrosis in vivo using MSOT and NIR fluorescence.

Public health relevance
Pancreatic cancer has poor negative resection margin rates with modern intraoperative imaging. We will develop a plectin-1 peptide probe to specifically target pancreatic cancer with near infrared fluorescent imaging to improve visualization in the operating room.